Hypothalamic regulation by thyroid hormone receptor phosphorylation

Three major thyroid hormone receptor (THR) isoforms, expressed from two genetic loci (Thra and Thrb), are
present in mammals: THRA1, THRB1, and THRB2. Thyroid hormone (TH) acting through THRs regulate food
intake metabolism and the hypothalamic-pituitary-thyroid (HPT) axis in man. Our laboratories have long been
interested in the THRB2 isoform as a central regulator of the hypothalamic-pituitary-thyroid (HPT) axis, given its
unique and limited-expression pattern. We recently found that THRB2 is heavily phosphorylated by both TH and
AMP kinase (AMPK) at an N-terminal serine site (S101-mouse, S102-human), not found in other THRs. Based
on increased food intake, obesity, and TH resistance in mice carrying a mutation of this phosphorylation
site (S101A), we hypothesize that an AMPK-dependent THRB2 S101 phosphorylation pathway in the
hypothalamus suppresses food intake and the HPT axis. We also hypothesize that dysfunction of this
pathway results in leptin resistance, increased food intake, and obesity (Fig. 1). Three closely related aims
are proposed: Specific Aim 1: Functionally co-localize hypothalamic THRB2 and AMPK action on feeding. Both
the arcuate (ARC) and ventromedial nucleus (VMN) regulate feeding in a THRB- and AMPK-dependent manner.
To begin to functionally localize THRB2 action in the hypothalamus, THRB2 will be removed from the POMC
neurons in the ARC and SF-1 neurons in the VMN using Thrb2 floxed mice and cell-specific Cre drivers. Cell-
specific KO of AMPKa2 in the same neurons will also be performed to understand AMPKa2’s role in feeding and
in the p-THRB2 pathway. Both male and female mice will be studied, given higher THRB2 expression in female
HA-tagged THRB2 mice. Specific Aim 2: Determine the role of THRB2 phosphorylation in feeding and mediating
hypothalamic leptin signaling. Previous studies have clearly demonstrated that leptin regulates both the HPT
axis and feeding. A potential mediator of leptin action is p-THRB2, given that S101A mice demonstrate leptin
resistance. A phospho-specific antibody was developed to probe this pathway further and will be used in a time-
course study of THRB2 phosphorylation during the fed-fasting transition. Furthermore, a phosphomimetic
S101D KI mouse model was generated to determine if this change protects against diet-induced obesity. Specific
Aim 3: Define the locus of TRH regulation by THRB2 during fasting. While fasting-induced suppression of the
HPT axis is mediated by reduced TRH expression in the paraventricular nucleus (PVN), it remains unknown how
HPT axis suppression is maintained in the setting of low TH levels. Strikingly, S101A mice display resistance to
fasting-induced TRH suppression, suggesting that THRB2 S101 phosphorylation is critical in the sensing of low
TH levels. This aim will determine the locus of fasting-induced and TH-dependent TRH suppression by targeting
neurons in the ARC and PVN. The mechanism of suppression will be explored further by studying if THRB2
phosphorylation is a common mechanism regulating the HPT axis and food intake.

Public health relevance
Changes in thyroid hormone action profoundly affect both metabolism and food intake in man. Hypothyroidism results in obesity, reduced energy expenditure (EE), and hypophagia, while hyperthyroidism causes weight loss, increased EE, and hyperphagia. We discovered a novel AMPK signaling pathway that phosphorylates a specific thyroid hormone receptor (THRB2) and suppresses the thyroid axis and food intake, establishing this pathway as a central regulator of the hypothalamus and suggesting it may be dysfunctional in human obesity.